Chronic Disease and Health Outcomes of Older Adults with Opioid Use Disorders

!
Project Summary/Abstract:
This project is a revised application for a Mentored Patient-Oriented Research Career Development Award. My
long-term goal is to be a leader in aging and addiction research with expertise in developing chronic care
delivery models coordinated within substance use treatment for older adults. This career award will provide
additional training and facilitate the completion of the proposed mentored research to continue my career
development into an independent clinician investigator. The proposed research addresses a critical knowledge
gap in the setting of an epidemic of older adults with substance use disorders. Although it is recognized that
older adults with opioid use disorders (OUD) are often medically and socially complex, very little is known
regarding their specific health status and needs of this vulnerable population. My proposed career
development plan will allow me to address this knowledge gap by working with a team of mentors as well as
with the New York City Department of Health and Mental Hygiene and the New York City Health + Hospitals'
integrated healthcare system who will supervise and collaborate on the following training goals: (1) to achieve
expertise in advanced quantitative methods as applied to large administrative datasets for addiction health
services research; (2) to develop skills in qualitative research theory and practice; and (3) to attain proficiency
and experience in the development of a care intervention. I will attain these training goals with guidance from
my mentorship team complemented by formal coursework and seminars, and by conducting a research
agenda that uses a mixed methods approach with the following specific aims: (1) describe the prevalence and
risk factors for high utilization of acute healthcare, high medical costs, multiple chronic conditions, and mortality
among older adults with OUD; (2) examine staff and patient attitudes, acceptance, and barriers regarding the
integration of geriatric models of care into opioid treatment programs; (3) develop and pilot for feasibility, a
geriatric-based care model for geriatric conditions and chronic disease management for older adults with OUD
to be tested in an R01. This proposal is directly aligned with the priorities of the National Institute on Drug
Abuse’s strategic planning workgroup on the "Complexity of Substance Use Disorders and the Continuum of
Substance Use Problems" to better understand substance use among individuals with complex conditions.
This research will set a future research agenda for widely integrating an evidence-based model of geriatric-
based chronic disease assessment and management into existing substance use treatment programs.
!

Public health relevance
! Project Narrative The Baby Boomer generation has high rates of substance use that will place increasing demands on the substance use treatment system. The proposed project will address the specific health issues among older adults with opioid use disorders with a focus on chronic disease management. The information learned from this project will help us understand the particular health needs of this growing population and to develop appropriate models of care. !